SON-mediated RNA splicing in glioblastoma

PROJECT SUMMARY
Glioblastoma multiforme (GBM) is the most common and lethal brain malignancy with a median survival of only
one year after diagnosis. Our current knowledge of the underlying basis of GBM centers mostly on several
recurrent mutations in specific genes. However, non-genetic factors contributing to GBM development and
progression are largely unknown. Due to our poor understanding of GBM biology, treatment options are limited
to chemotherapy (temozolomide, TMZ) combined with radiotherapy. Thus, new therapeutic approaches are
desperately needed to treat this deadly tumor. Emerging evidence has demonstrated that aberrant RNA
splicing due to splice site mutations and/or splicing factor mutations drives oncogenic gene expression in
multiple types of solid tumors and hematologic malignancies. In GBM, a few RNA splicing factors, including
polypyrimidine tract-binding protein 1 (PTBP1) and hnRNP A2B1 have been recently identified as driving
factors in oncogenic splicing, indicating that RNA splicing is a critical, yet to be explored, mechanism that
governs a broad range of oncogenic gene expression. Our extensive preliminary data demonstrated that SON,
a large nuclear speckle protein possessing DNA- and RNA-binding abilities, is highly upregulated in GBM
patient samples, and there is a strong correlation between SON upregulation and short patient survival. We
found that SON facilitates expression of PTBP1, thereby activating the PTBP1-meditated oncogenic splicing
program. In contrast, SON inhibits the expression of PTBP2, a splicing factor required for neural exon inclusion
and neural differentiation. We further revealed that SON regulates the intron removal process at the
constitutive splice site in the PTBP1 transcript and regulates cassette exon inclusion/skipping at the alternative
splice site in the PTBP2 transcript. We also demonstrated that SON knockdown markedly inhibits GBM cell
growth and neural stem cell gene expression, and SON depletion renders patient-derived glioma stem cells
(GSCs) sensitive to TMZ in vitro. Based on our preliminary data, we hypothesize that SON is a master RNA
splicing regulator positioned at the apex of the splicing factor hierarchy that affects both constitutive and
alternative RNA splicing, consequently turning on the oncogenic splicing program and blocking neural splicing.
Thus, SON could represent a promising novel therapeutic target for GBM. To test this hypothesis, we propose
to dissect the molecular mechanisms of SON functions in the regulation of constitutive and alternative RNA
splicing in GBM (Aim 1), and to determine the therapeutic potential of targeting SON in vivo (Aim 2).
Successful completion of this proposed study will significantly advance our knowledge of abnormal gene
expression in GBM and provide a fundamental rationale for future endeavors to develop SON inhibitors.

Public health relevance
PROJECT NARRATIVE Glioblastoma multiforme (GBM) is the most common and lethal brain malignancy with no targeted therapy available. This project is to achieve a comprehensive understanding of SON functions in altering the RNA splicing program in GBM and to evaluate the therapeutic potential of targeting SON in vivo. The knowledge generated from this study will advance our understanding of the functional significance of RNA splicing in GBM and will lead to the development of a novel strategy for targeted therapy.